Multi Parametric Total-Body Imaging of Immune Activation in Post Acute Sequelae of SARS-CoV-2 (PASC)

Project Summary/Abstract
Post-acute sequelae of SARS-CoV-2 infection (PASC) is a persisting health challenge characterized by a range
of symptoms affecting multiple organ systems, which continues to impact approximately 10% of COVID-19
survivors. Multiple, potentially overlapping, mechanisms have been identified that may play a role in PASC.
However, with no effective preventative measures or treatments, there is a critical unmet need for understanding
the pathophysiology of PASC; as previous studies, often limited by focus on peripheral blood biomarkers only or
confined to single organ systems, have not sufficiently and quantitatively investigated the multisystemic and
immune-related complexities of this condition in non-blood tissue. The long-term objective of this project is to
bridge this knowledge gap by providing insight into the immune and systemic manifestations of PASC, through
the innovative use of total-body dynamic positron emission tomography (PET) with the 18F-AraG radiotracer,
which particularly offers selectivity towards activated T cells. To achieve this, we will use the dynamic PET
images obtained from a high-sensitivity total-body PET scanner to develop, optimize, and validate a kinetic model
for 18F-AraG in different anatomical sites and tissue types for multi parametric quantification of uptake. We expect
that this will not only improve the quantification accuracy compared to standard static imaging, but also can shed
light on the underlying mechanisms of uptake. The multi parametric imaging will be firstly used to identify sites
of immunological perturbation in PASC patients, offering a total-body view of tissue-level manifestations of
PASC. For this, we will compare the kinetic parameters of different tissues between symptomatic PASC
participants and a control group consisting of individuals with a complete COVID-19 recovery. Second, we will
integrate the multiparametric imaging data with peripheral blood assays, aiming to assess the correlations
between certain 18F-AraG kinetic parameters and biomarkers of inflammation, immune dysregulation, and
endothelial dysfunction in peripheral blood. Particularly, to identify vascular alterations in tissue and their
association with endothelial markers in blood, we will use vascular permeability modeling to estimate the blood
flow in different tissues from the early frames of the kinetic data. Third, we will employ a longitudinal design to
quantify changes in 18F-AraG kinetic parameters and correlate them with evolving PASC symptom profiles over
time. We will include two follow-up scans of the PASC participants at 4 months and 8 months after the baseline
scans with systematic symptom assessments, focusing on individual patient trajectories. Through this, we expect
to establish a direct and meaningful connection between molecular imaging data and clinical manifestations. In
summary, the incorporation of cutting-edge imaging technology with quantitative modeling techniques for non-
invasive evaluation of total-body immune response, combined with the longitudinal design of the study promises
to provide unprecedented insights into this complex condition and would extend well beyond the confines of the
PASC condition, offering frameworks and tools that could as well be used for other post-viral conditions.

Public health relevance
Project Narrative Post-acute sequelae of SARS-CoV-2 infection (PASC) is a multisystemic condition estimated to affect 10% of COVID-19 infected people world-wide, which is characterized with a variety of persistent or newly emerged symptoms that can last for months or years following the acute phase of SARS-CoV-2 infection. This project aims to provide insights into the immune and systemic manifestations of PASC by utilizing total-body dynamic positron emission tomography (PET) and kinetic modeling of 18F-AraG radiotracer, that particularly offers selectivity towards activated T cells, and to provide a link between multi parametric imaging data and biomarkers of immune dysregulation in peripheral blood as well as the symptomology in PASC patients. The incorporation of cutting-edge imaging technology with quantitative modeling techniques for non-invasive evaluation of total- body immune response, along with the longitudinal design of the study are not only expected to contribute to understanding the complex pathophysiology of PASC, but also could provide tools that are applicable to other post-viral conditions, forging a path towards personalized diagnostics and interventions.